Administrative Core

The objectives of Core A in the Center for Molecular Analysis of Diseases Pathways are to provide administrative leadership and coordinate the overall research efforts of the project investigators in the Center. This core will also be responsible for accounting and grant management, identification of mentors for junior investigators and selection of new projects. Formal and informal reviews of the center and center projects will be conducted by the internal and external advisory boards on a regular basis. The administrative core will provide oversight and direction of the three core labs as well as the identification and facilitation of the purchase of major instrumentation. Short courses and workshops on grant writing and technical areas of importance to the center will be administered through this core along with annual symposia. The most important activities of this core will be to facilitate the graduation of junior investigators to RO1 funding and the identification and recruitment of new junior investigators throughout the state of Kansas whose research fits into the theme of Molecular Analysis of Disease Pathways.

Public health relevance
The COBRE Center on Molecular Analysis of Disease Pathways at the University of Kansas involves a group of scientists who are conducting health related research into the biochemical and genetic basis of disease. This core activity provides leadership and administration support to the Center.